Illumination of TAAR2 Location, Function and Regulators

Project Summary
This proposal is prepared in response to RFA-RM-22-024, which invites “Pilot projects investigating
understudied G protein-coupled receptors, ion channels and protein kinases”. We choose to study trace amine
associated receptor 2 (TAAR2) which is an understudied GPCR and an IDG-eligible protein under this FOA.
TAAR2 was discovered as a GPCR in 2001 and has been speculated to be involved in neurological and
psychiatric diseases; however, little progress has been made towards understanding the action of TAAR2 and
creating experimental tools. To address the current knowledge gap, we will investigate TAAR2 cellular and
subcellular localization, trafficking and signal transduction using human SH-SY5Y cells and rodent brains.
Further, this proposal will also apply CRISPR/Cas9-mediated homology-directed repair mechanism to tag
Taar2 gene in SH-SY5Y cells so that TAAR2-interacting protein network can be revealed through proteomics.
Knowledge learned and products generated from this proposal will add value to the IDG program and
importantly, lay ground work for future investigation of TAAR2 in animal models of human diseases.

Public health relevance
Project Narrative There is an increasing appreciation of the involvement of trace amine-associated receptors (TAARs) in the regulation of reward, cognition and mood disorders; however, there is very little knowledge regarding the action of TAARs. This project will illuminate the function, cellular localization and proteomics of TAAR2, a subtype of TAARs. Completion of the project may potentially lay the ground work for future studying the role of TAAR2 in human diseases.